Time-Resolved and Multi-Temperature Structural Biology to Understand Dynamic Enzyme Catalysis

Project Summary
Enzymes, proteins which perform chemical reactions, are required for all of life. These proteins are amazing and
specific catalysts that are tightly regulated to ensure proper cellular function. Dysregulation of enzymes is
associated with many diseases, and inhibitors, which bind to and turn off enzymes, are often used as drugs to
modulate an enzyme’s activity and cure or manage diseases. Much has been learned about enzyme function
and mechanism via structural biology, which informs researchers of the structure of the enzyme, and kinetics
experiments, which yield information about how well the enzyme binds its substrate and how fast the reaction
proceeds. However, these experiments do not capture the structure of the enzyme as it performs its catalysis or
give information about the changes in enzyme structure under different conditions. Such information would
improve our understanding of how enzymes function, improving rational enzyme design outcomes that design
enzymes with new activities or other beneficial properties like improved stability or temperature adaptations, and
improving inhibitor and drug design outcomes which would benefit from knowledge of the enzyme in different
states. One of the goals of the proposed research is to combine enzyme structure and enzyme kinetics into one
experiment using time-resolved structural biology, which collects atomic resolution enzyme structure along the
biochemical reaction pathway, uncovering reaction intermediates and structural fluctuations with millisecond time
resolution. This work builds upon our previous work and method development by applying milli-second mix-and-
quench crystallography (MMQX) to new enzyme systems which are active drug targets due to their importance
in metabolism. Specifically, we are applying our methods to amino acid catabolism enzymes, which break down
amino acids, the building blocks of proteins, into other components to drive growth in the living cell. In addition,
we are also developing methods and studying these and other enzymes via multi-temperature crystallography,
which perturbs the energy landscape of these enzymes and causes their structures to fluctuate as they find their
equilibria at the new temperature. These multi-temperature experiments have previously been demonstrated to
observe loop opening and closing, cryptic and allosteric binding sites, and differential inhibitor binding to standard
cryo-crystallography experiments. These research programs seek to better understand enzyme dynamics and
catalysis, which will improve human health by increasing the success rate of future enzyme engineering and
inhibitor design studies.

Public health relevance
Project Narrative Enzymes are dynamic and flexible proteins that catalyze chemical reactions in the living cell. These motions are vital to the proper functions of these enzymes as well as the discovery of drug candidates to modulate the activity of these molecules. The project studies the dynamics of enzymes involved in metabolism by time-resolved structural methods and develops techniques to observe the movements of these flexible proteins in response to stimuli, which will improve our understandings of these important molecules.